Acute Modulation of Stereotyped High Frequency Oscillations with a Closed-Loop Brain Interchange System in Drug Resistant Epilepsy

Project Summary:
High frequency oscillations (HFOs) of intracranial EEG (iEEG) have the potential to identify the surgical resection
area/seizure onset zone (SOZ) in patients with drug resistant epilepsy. However, multiple reports indicate that
HFOs can be generated not only by epileptic cerebral tissue but also by non-epileptic sites often including
eloquent regions such as motor, visual and language cortices. In this project, we present the initial evidence of
a recurrent waveform pattern that may be sufficient to distinguish pathological HFOs from physiological ones.
Specifically, we show that the SOZ repeatedly generates sets of stereotypical HFOs with similar
waveform morphology whereas the events recorded from out of SOZ were irregular. This morphological
pattern served as a robust neurobiomarker to isolate SOZ from other brain areas in multiple patients
consistently. While these promising preliminary results are in place, the functional utility of stereotyped
HFOs in a closed-loop seizure control system remains unknown.
As of today, not much is known whether the stereotyped HFOs generated by the SOZ can be detected with an
implantable system. If this can be achieved, then HFOs can be strategically translated as a neurobiomarker into
closed-loop seizure control applications. We hypothesize that pathologic stereotyped HFOs can be captured
with the implantable Brain Interchange (BIC) system of CorTec and spatial topography of these events can be
utilized by the implantable system to deliver targeted electrical stimulation to achieve seizure control. Using an
acute setup within the epilepsy monitoring unit (EMU), this project will investigate the feasibility of capturing
stereotyped HFO events using the new BIC system and compare the detection results to those obtained with
the commercially available amplifier. If the first phase (Aim-1) of our study becomes successful, later in the
second phase (Aim-2), once again in the EMU, we will deliver targeted electrical stimulation to those brain sites
associated with stereotyped HFOs using the BIC. We will investigate the modulatory effects of this closed-loop
stimulation strategy by monitoring the changes in signature events such as spikes, epileptic discharges, ripples
and fast ripples.
If successful, this closed-loop system does not have to wait for a seizure to start in order to deliver the stimulation
at its onset as done by the RNS system of Neuropace. In contrast, the system will monitor the spatial topography
and rate of stereotyped HFOs and deliver targeted stimulation to these areas to prevent seizures from occurring.
If the outcomes of our research in acute setting become successful, we will execute a clinical trial and run our
methods with the implanted BIC system in a chronic ambulatory setting.
1

Public health relevance
Project Narrative Overall, this proposal will investigate the functional utility of stereotyped HFOs by capturing them with a new implantable system (Brain Interchange - BIC of CorTec), which can sample neural data at higher rates >=1kHz and deliver targeted electrical stimulation to achieve seizure control. In contrast to current closed-loop systems (RNS), which wait for the seizure to start before delivering stimulation, the BIC system will monitor the spatial topography and rate of stereotyped HFOs and deliver targeted stimulation to these HFO generating areas to prevent seizures from occurring. If the outcomes of our research in acute setting become successful, we will execute a clinical trial and run our methods with the implantable BIC system in a chronic ambulatory setting. 1